Sex Difference in Cocaine-Induced Impulsivity: Contribution of the Mesocorticolimbic Dopamine System and Estradiol

Project Summary/Abstract
Female drug users escalate to more problematic patterns of drug use more rapidly than male drug users.
Further they exhibit greater dysregulation in their drug-taking behavior. It is hypothesized that fluctuations in
circulating ovarian hormones (estradiol and progesterone) contribute to the variability in drug-taking
behavior. For example, when estradiol levels are high, females exhibit enhanced cocaine-self-
administration, cocaine reward and increased cocaine-induced locomotor activity. Furthermore, estradiol
enhances psychostimulant-mediated dopamine release. We have recently found that female rats exhibit
enhanced cocaine-induced impulsive action and exhibit increases in D1 receptors in brain regions
regulating impulsivity. The goals of this proposal are to determine 1) if dopamine D1 receptors contribute to
the enhancement of cocaine-induced impulsivity in female rats, 2) if cocaine-induced impulsivity fluctuates
across the estrous cycle and, 3) if exogenous administration of either estradiol or progesterone affects
cocaine-induced impulsivity in ovariectomized rats. In all cases impulsive action will be measured using the
5-choice serial reaction time (5CSRT) task and the differential reinforcement of low rates of responding
(DRL) task. Additionally, we will determine if ovarian hormones affect the expression dopamine-related
proteins (e.g., D1 receptors, D2 receptors, tyrosine hydroxylase, dopamine transporter, and the vesicular
monoamine transporter) in brain areas that regulate impulsive action (e.g., prefrontal cortex, ventral
striatum, dorsal striatum) using Western blots. This work will determine if changes drug-induced impulsivity
could contribute to observed sex differences in drug-taking behavior; ultimately this may lead to more
targeted approaches to treatment. Furthermore, this work will help inspire and train undergraduate
researchers at Oberlin College to conduct experiments that involve a unique combination of behavioral and
molecular techniques. Not only will students learn a variety of techniques, but they will be involved in the
experimental design, data collection and analysis, presentation of data at conferences and the preparation
of resulting manuscripts. Thus, this proposal will enhance the students’ education and will enhance the
research environment at Oberlin College.

Public health relevance
PROJECT NARRATIVE Female cocaine users exhibit dysregulated patterns of drug use relative to males; this may be related to changes in drug-induced impulsivity. Changes in circulating ovarian hormones affect patterns of cocaine use and the functioning of the mesocorticolimbic dopamine system; a neurotransmitter system that contributes to impulse control. The goals of this proposal are to investigate a) the contribution of dopamine D1 receptors to sex differences in cocaine-induced impulsivity, b) to investigate whether cocaine-induced impulsivity and dopamine-related proteins in the mesocorticolimbic dopamine system fluctuate across the estrous cycle and c) to investigate whether exogenous administration of estradiol and/or progesterone affect cocaine-induced impulsivity and dopamine-related proteins in the mesocorticolimbic dopamine system.